EVALUATION OF THE URISCREEN RAPID TEST FOR THE DETECTION OF BACTERIA IN URINE

The majority of specimens received in diagnostic microbiology laboratories for culturing are urine specimens. Rapid screening of urines can provide results in a timely manner, allowing prompt patient care, and eliminating the need to culture specimens that are negative. The Uriscreen is a 2 minutes, nonautomated urine screening method for the detection of bacteria and leukocytes. This study will evaluate the ability of the Uriscreen to detect a positive urine specimen as compared to routine bacteriological culture.